SEPARATION METHODS FOR COMPLEX MIXTURES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are developing methods to handle complex mixtures that arise from biological samples (e.g., whole cell lysates). Strategies include both on- and off-line two-dimensional HPLC, orthogonal HPLC strategies, small diameter high pressure HPLC and affinity purification.